Reliable and robust causal inference approaches for effective connectivity research with fMRI data

Neuroscientists grapple with understanding the causal mechanisms within brain networks that govern
perception, cognitive functions, decision-making, and behavior. To understand these mechanisms,
researchers have attempted to translate statistical associations between brain regions (so-called functional
connectivity) into causal relationships, raising the question of whether one brain region has a direct
influence on the physiological activity recorded in other brain regions. Such causal relationships are called
effective connectivity. Effective connectivity is essential in learning how neural activities in different regions
are causally related. It also provides important evidence for designing future experiments aiming at
affecting certain cognitive outcomes by intervening on specific neural processes. Several methods have
been developed for identifying and estimating effective connectivity, including Granger causality and
dynamic causal modeling. However, these existing methods are vulnerable to spurious associations due to
the shared network, temporal, and spatial dependence structures found in neuroimaging data. Moreover,
they are not often explicit about the assumptions on unmeasured confounders, such as whether and how
much unobserved neural activities that affect multiple brain regions are allowed when determining effective
connectivity. These two common sources of spurious and biased findings can readily mislead our
understanding of effective connectivity, resulting in poorly designed experiments or interventions for
improved cognitive functions. The goal of this proposal is to develop reliable and robust causal inference
methods to infer effective connectivity between brain regions that account for the shared dependence
structures as well as unmeasured confounding factors. This proposed research will raise awareness of
potential sources of bias and misleading findings in neuroimaging (e.g., fMRI) data, as well as provide
more reliable and robust inferential tools than existing methods that are often relying on a single p-value
from a single parameter in the presumed parametric model. This pilot research will pave the way for future
independent funding that will further investigate effective connectivity among multiple brain regions that are
robust to many sources of spurious findings.